Outreach Core

SUMMARY: OUTREACH CORE
The goals of the scientific portion of this proposal are directed towards bringing personalized medicine to the
clinic for glioblastoma patients through integrative mathematical methods. Effectively bringing computational
results into the clinic requires a broader understanding of the methods and general principles by scientists,
clinicians, and patients alike. More scientists need to be aware of these non-traditional techniques in order to
build additional models and enhance methodology for the clinic. Interpretation of model output for use in therapy
will require clinicians to have a solid understanding of a given model’s strengths and limitations. Also, for patients
to choose and feel confident in therapies directed by these techniques, they will require a broader awareness of
the existence, potential benefit, and value of these therapies. The primary goal of the Outreach Core is to
disseminate knowledge of mathematical oncology and cancer systems biology to students, colleagues, and the
general public. To accomplish our goal, we will strive to appeal to each target group through the following:
Training new cross-disciplinary scientists. We will recruit undergraduate and graduate students along with
postdoctoral trainees at our various institutions, providing them with opportunities for research and improving
cross-disciplinary understanding. For undergraduates, this will take the form of internships, senior thesis projects
and summer research experiences. For graduate students and postdoctoral trainees, this will take the form of
longer-term research projects possibly culminating in master’s thesis and/or doctoral dissertation projects.
Inform the research community. Beyond presenting our work at conferences targeting many different
audiences, we will design conferences and workshops to attract clinicians and research scientists from multiple
disciplines to inspire and update them about emerging research at the interface of oncology, mathematical
modeling, and imaging.
Engage with the general public. We will develop an online, easily accessible presence by creating a website
and using social networking platforms including Twitter, YouTube, and Facebook. We will work with Mayo Clinic
patient advocacy groups to engage brain tumor patients and their families by hosting informational workshops
for brain tumor advocacy groups in our PNT lab at Mayo Clinic. In addition, we will partner with the Mayo Clinic
Cancer Education Center to host the general public through evening and weekend workshops designed for a lay
audience.
Outcome assessment We will assess the success of our outreach efforts across each sphere of influence.

Public health relevance
NARRATIVE: OUTREACH CORE Getting computational results into the clinic requires a broader understanding of the methods and general principles by scientists, clinicians, and patients alike. Thus, the primary goal of the Outreach Core is to disseminate knowledge of the iterative dialogue between mathematical oncology, cancer systems biology and experimental and clinical oncology to students, colleagues, and the general public. To accomplish our goal, we will train new cross-disciplinary scientists, inform the research community, engage with the general public, and assess our outcomes.